ADMINISTRATIVE

The objective of Core A is to organize and administrate the activities of the Program Project. The specific tasks include keeping track of personnel, ordering and monitoring purchase of supplies, equipment, and other expenses to include travel arrangements and review of the monthly financial reports on each project. Core A will also be responsible for arranging the group meetings, and writing up the meeting notes. Core A will also include a biostatistics group lead by Dr. Ronald Thomas that will provide expertise in biostatistics and manage a web-based database for the projects/core.

Public health relevance
RELEVANCE (See instructions): Core A will provide administrative support and leadership in the interactions of the individual projects and cores for this program project, which will study the causes of Alzheimer's disease and to develop potential new treatments. This research will promote "healthy cognitive aging" by testing the effects of physical exercise on brain structure and function.